Examining striatal synaptic function across mouse models of autism spectrum disorder (ASD)

ABSTRACT
Autism spectrum disorder (ASD) is a neurodevelopmental disorder classified by two major diagnostic criteria -
persistent deficits in social communication and interaction, and the presence of restricted, repetitive patterns of
behavior. The striatum, the main input center of the basal ganglia, has been implicated in the presentation of
repetitive behaviors given its roles in action selection, motor learning and habit formation. Despite clear links
between striatal functions and ASD-related behavioral alterations, the striatum, and basal ganglia in general,
remain relatively underexplored in ASD research. Recent work from our lab and others has shown that striatal
cell type-specific deletion of ASD risk genes in mice is sufficient to increase performance on the accelerating
rotarod task, a striatum-dependent motor learning assay used as a proxy for acquired repetitive behaviors. We
further showed that this enhanced motor learning is associated with increased corticostriatal excitatory
connectivity. Together this work suggests that enhanced corticostriatal drive may promote the acquisition of fixed
motor routines in the context of ASD-related genetic perturbations.
In this proposal, I will test the hypothesis that striatal, in particular corticostriatal, connectivity and synaptic
plasticity is commonly altered across mouse models of ASD that harbor mutations in a range of risk genes. In
addition, I will determine how mutations in ASD-risk genes impact striatal-dependent motor and habit learning. I
will focus on three mouse models of autism, with disruption in ASD-risk genes that code for a range of protein
types: Cntnap2, which codes for a synaptic adhesion molecule, Pten, which codes for phosphatase that
negatively regulates AKT and mTOR signaling, and Scn2a, which codes for a voltage-gated sodium channel. I
will determine the potential alterations in striatum-dependent behaviors in these models by utilizing behavior
assays that assess learned motor behaviors thought to be dependent on corticostriatal synaptic transmission. I
will then assess the impact of these mutations on the physiological properties of spiny projection neurons (SPNs),
the main output cells of the striatum, and attempt to rescue alterations in habitual motor behaviors by modifying
SPN excitability. These experiments will increase our understanding of how striatal pathophysiology contributes
to ASD and may identify points of convergence at the synaptic or circuit level that are shared across genetically
diverse forms of ASD. Such an outcome may enable the design of therapeutics that can restore striatal function
in the context of ASD.

Public health relevance
PROJECT NARRATIVE Autism spectrum disorder (ASD) is a genetically heterogeneous group of disorders with primary symptomology that includes social impairments and restricted, repetitive patterns of behavior. The proposed research will utilize multiple genetic mouse models of ASD to test the idea that synaptic alterations in a brain region called the striatum underlie the repetitive, inflexible behaviors associated with ASD. An understanding of how this brain region is impacted by ASD-related mutations will increase the possibility of developing therapeutic interventions that may be effective across multiple genetic types of ASD.